Novel Polymer-antibody Conjugates as Long-acting Therapeutics for Ocular Diseases

PROJECT SUMMARY
Wet age-related macular degeneration (AMD), a chronic eye disorder, is one of the leading causes of
irreversible blindness and impacts approximately 3 million people (~200,000 each year) in the US alone. Wet
AMD is characterized by aberrant angiogenesis under the retina and macular, which is induced by vascular
endothelial growth factors (VEGFs). To this end, most therapeutic efforts have focused on developing drugs
that inhibit VEGFs (anti-VEGFs), which are now the standard treatment for wet AMD. Several FDA-approved
anti-VEGF biologics include full antibodies and antigen-binding fragments (Fab) against the VEGF protein that
are delivered intravitreally on a routine basis. Although effective, anti-VEGF intravitreal injections must be
administered every 4-8 weeks, resulting in complications such as secondary infections, retinal detachment,
retinal hemorrhage as well as lack of patient adherence to a treatment schedule. Thus, there remains a critical
need to develop long-acting formulations of these vision-saving drugs. One overarching limitation to developing
long-acting formulations has been tied to inefficient drug delivery systems, which are plagued by shortcomings
that lead to denaturation of the payloads, low drug loading efficiency, batch-to-batch variations in molecular
weight (MW) and purity, high viscosity, and lack of control in the enzymatic degradation in vivo and improper
degradation of the protein. To address these limitations, Delgen Biosciences Inc. seeks to adapt its long-acting
and sustained release system as a novel drug for wet AMD by conjugating it to the FDA-approved VEGF
inhibitor, ranibizumab. This technology is based on a novel Molecular Brush Polymer (MBP) platform
technology developed in Dr. Wei You’s lab at UNC Chapel Hill. In this project, Delgen will focus on the
development of long-acting ocular therapeutics for wet AMD based on MBP-therapeutic protein conjugates. A
strength of this application is the strong preliminary data for the proposed approach, including (a)
demonstrated ability to generate PEGylated MBPs with a radius of hydration (RH) up to an unprecedented 10
nm and (b) precisely controlled degradation of MBPs results in uniform low-MW side chain polymers. The goal
of our Phase I SBIR is to develop molecular polymer brushes (MBPs) conjugated with anti-VEGF antibody
fragments (MBP-Fabs), which can significantly enhance drug loading, slow down ocular clearance, and
increase the half-life of Fab in the eye. Specifically for this proposal, we intend to conduct critical proof-of-
concept studies to synthesize and identify an MBP-Fab lead formulation and demonstrate its ocular tolerance
and increased half-life in vivo. Successful outcomes of the project can lead to greatly improved therapeutic
solutions for the treatment of wet AMD. The proposed research will lay the foundation for the development of
novel MBP based delivery platforms that can have broader biopharmaceutical applications beyond ophthalmic
drugs and ultimately help unleash the greater potential of today’s fast-advancing biological therapeutics.

Public health relevance
PROJECT NARRATIVE Wet age-related macular degeneration (AMD), a leading cause of permanent vision loss in the US, is treated with vascular endothelial growth factor inhibiting (anti-VEGF) drugs that require repeated injections directly into the eye. Given that the high injection frequency can reduce patient compliance and treatment efficacy, Delgen Biosciences Inc. is developing a novel, long-acting drug for wet AMD using an FDA-approved anti-VEGF treatment conjugated to an innovative Molecular Brush Polymer (MBP), a platform technology, to enhance its duration of action. The goal of this Phase I is to synthesize and evaluate the ocular tolerance of this novel therapy, which stands to improve standard of care by reducing the frequency of injections and increasing the drug’s efficacy and patient adherence to treatment.